PACLITAXEL, GALLIUM NITRATE &FILGRASTIM IN PATIENTS WITH SELECTED MALIGNANCY

To determine the maximum total dose of paclitaxel when given with gallium nitrate and assess the objective response rate, duration of remission and overall survival in patients treated with paclitaxel plus gallium nitrate plus G-CSF.